CORTICOSTEROID TREATMENT ON ENERGY METABOLISM IN BRONCHOPULMONARY DYSPLASIA

Effect of Corticosteroid treatment on energy metabolism as measured by CO2 production in patients with Bronchopulmonary Dysplasia.